RESEARCH PLANNING FOR CANCER PREVENTION AND CONTROL

Drew Medical School, working in conjunction with Meharry and Morehouse Medical Schools, will undertake research planning for cancer prevention and control. The purpose of the planning is: 1) To develop a plan which specifies the essential parameters of an on-line data base system which would serve as a prime resource for research action; 2) To develop an organizational plan for research management, staff recruitment, training, financing of a local regionalized effort in cancer prevention and control research. 3) To develop a 5 year plan which defines specific sets of research questions, methodology and designs which are likely to yield immediate results for a prevention and control agenda. We anticipate that at the end of the planning period we will have the following outcomes: 1) A written plan for an on-line cancer data base. 2) A clearly defined plan of an organization structure to promote research. 3) A written 5 year research agenda with specific research protocols. The planning is expected to strengthen the infrastructure resulting in the submission of a significantly increased number of RO1 grants in cancer prevention and control coming from Drew.